SANDOZ CV205-502 VS. BROMOCRIPTINE IN MICROPROLACTINOMA

The purpose of this study is to compare the medication CV2050502 to bromocriptine in both effectiveness and incidence and severity of side effects in treating patients with microprolactinomas.